Dissecting the role of the PICALM/EED locus on myeloid cells in Alzheimer's disease.

Project Summary
Alzheimer’s disease (AD) is a progressive neurodegenerative disease affecting more than 50 million people
worldwide, but the mechanisms involved in disease development remain poorly understood. Genome-wide
association studies have uncovered numerous loci associated with disease, but identifying causal variants and
genes remains a challenge. Studies have revealed that AD risk variants are enriched in active enhancers of
human monocytes, macrophages, and microglia, suggesting many of these variants act by disrupting gene
expression specifically in myeloid cells. In addition, many genes implicated in AD risk are highly expressed in
myeloid cells, strongly implicating these cell types in the etiology of AD. By integrating human genetics with
epigenomic and transcriptomic datasets from human myeloid cells, we identified a myeloid cell enhancer
containing an AD-associated functional variant on chromosome 11, and two putative target genes of this
enhancer, embryonic ectoderm development (EED) and phosphatidylinositol binding clathrin assembly protein
(PICALM). EED is an essential subunit of the polycomb repressive complex 2 (PRC2) known to function in
regulation of gene expression and clearance behavior in mouse microglia, but it remains relatively unstudied in
the context of AD in human cells. PICALM is an adaptor protein known to function in endolysosomal pathway
and autophagy, but its role in microglia remains unknown. The overall goal of this proposal is to understand
how our nominated AD risk enhancer influences the expression of its two target genes PICALM and EED,
and to test the hypothesis that these two potential causal genes regulate microglia functions
downstream of TREM2. In Aim 1, I will determine the role of the candidate AD risk enhancer in regulating the
expression of PICALM and EED and human microglial cell function by combining CRISPR gene editing in human
induced pluripotent stem cells (iPSCs), microglial differentiation protocols, and xenotransplantation methods
involving direct injection of microglia precursor cells into the mouse brain. I will delete the candidate enhancer
region and perform transcriptomic and epigenetic profile of edited microglia via RNAseq and ATACseq in addition
to microglia functional assays. To assess the in vivo consequences of deleting the risk enhancer in microglia, I
will transplant the edited microglia into the brains of wildtype and 5xFAD humanized mice and characterize
transcriptomic profile of these microglia via snRNAseq analysis and perform immunohistochemistry. In Aim 2, I
will investigate how PICALM and EED regulate human microglia function, namely TREM2 mediated
efferocytosis, or phagocytic pathway. I will determine the subcellular localization of PICALM and EED using
biochemical and imaging techniques and test the role of these two genes in microglial functions downstream of
TREM2 signaling such as actin rearrangement, phagosome formation, and downstream kinase signaling. My
proposed aims will help understand the mechanisms in which the causal variants and target genes drive
the AD risk, and enhance our understanding of PICALM and EED in microglia and in AD.

Public health relevance
Project Narrative While genetic studies have identified more than 75 genetic loci implicated in Alzheimer’s disease risk, the underlying causal genes and biological mechanisms involved in disease development remain unclear. This proposal combines patient-derived induced pluripotent stem cells, genome editing, and innovative transplantation techniques to experimentally investigate the impact of prioritized genes and enhancers on the cellular function of disease-relevant microglia both in vitro and in vivo. This approach will translate findings of genomic studies from statistical associations to biological function and enhance our understanding of the contribution of PICALM/EED locus to disease development.